Intestinal lysozyme controls mucosal immune response to microbiota

PROJECT SUMMARY:
Intestinal Paneth cells and some myeloid cells secrete lysozyme, a glycoside hydrolase that catalytically cleaves
bacterial cell-wall as well as exerts bactericidal activity through a non-enzymatic domain. This feature uniquely
distinguishes lysozyme from other antimicrobial peptides. Elevated levels of intestinal lysozyme and its ectopic
production by colonic mucosa are observed in clinically active intestinal inflammation conditions. Recent studies
described defective lysozyme packaging and secretion in Paneth cells of Crohn’s disease (CD) patients.
Unfortunately, existing literature suggested both a colitis-promoting and a colitis-protective role of lysozyme. The
human LYZ gene is located in the vicinity of an Ulcerative Colitis (UC) risk locus, and patients with LYZ mutations
exhibit IBD symptoms. Despite of these strong associations of intestinal lysozyme with UC and CD, surprisingly
little is known about its exact physiological functions in regulating gut microbiota and mucosal immune response.
This knowledge gap exists due to a lack of models for direct study of lysozyme in vivo function. This gap prevents
us from fully understanding the clinical implication of lysozyme in the progression and management of distinct
IBD forms. We have developed several mouse models to facilitate functional investigation of intestinal lysozyme
under its deficient or over production conditions. Preliminary data suggest that lysozyme deficiency leads to a
dysbiosis with an expansion in certain IBD-related bacterial species. When barrier function is acutely
compromised, there is an enhanced translocation of opportunistic pathobionts and exacerbated colitis in these
mice. Further analyses uncovered lysozyme sensitive microbes, an unexpected impact on epithelial cell
differentiation and composition, as well as an influence on the mucosal immune response. This innovative project
will investigate how lysozyme defects affect the colonization of IBD-related bacteria, how lysozyme-sensitive
species modulate gut mucosa, and how lysozyme and bacterial interaction influences the progression and
resolution of different experimental IBDs with distinct inflammatory profiles. The central hypothesis is that
intestinal lysozyme modulates gut microbial community and its impact on mucosal immune responses to regulate
inflammatory tone and the susceptibility of IBD. This hypothesis is formulated on the basis of preliminary data
and existing literature. Two highly cohesive aims will first delineate the impact of lysozyme on gut microbiota,
the regulation of mucosal homeostasis and inflammation by the lysozyme-sensitive microbiota, and will then
examine the contribution of lysozyme defects to distinct forms of experimental colitis of different immunological
profiles, with a particular effort devoted to understanding the role of type 2 immune signaling in these processes.
This MPI project is constructed on complementary and indispensable expertise of the two PIs in experimental
colitis, mucosal immunology, gnotobiotics study, genetics, and intestinal epithelial biology. The project utilizes
rigorous genetic approaches and is expected to produce unique and disease-relevant insights into intestinal
lysozyme and its impact on microbiota, mucosal immunology, and IBDs.

Public health relevance
PROJECT NARRATIVE: By using genetically engineered mouse models and gnotobiotic studies, this project proposes to investigate the physio-pathological function of intestinal lysozyme in regulating mucosal immune responses to microbiota in homeostasis and during colitis development. Findings from this research will be relevant for developing strategies to intervene in dysbiosis and the pathogenesis of distinct forms of inflammatory bowel diseases.